Genomics Shared Resource

Program Director/Principal Investigator (Last, First, Middle): Chu, Edward
GENOMICS SHARED RESOURCE - PROJECT SUMMARY/ABSTRACT
The Genomics Shared Resource (GSR) integrates our legacy Genomics, Epigenomics, Computational
Genomics and Molecular Cytogenetics core facilities. As a result of this integration, we have combined the
activities and expertise of individuals in core facilities performing closely related work into a unified entity that
enhances efficiency and quality of services so that cancer researchers can hand off samples to core personnel
and receive analyzed data, providing a complete workflow housed in a single facility.
The GSR is now implementing long-read sequencing services in addition to short-read services. When
appropriate, we facilitate outsourcing of short-read sequencing to low-cost commercial providers. However, we
have recently purchased the Illumina NextSeq 2000 platform that upgrades our short read sequencing
capabilities. This investment anticipates a substantial drop in reagent costs in the next 1-2 years and migration
of some of the currently outsourced sequencing back into the GSR.
The GSR has also been proactive in optimizing new single cell assays for researchers with a current focus on
single cell RNA-sequencing and chromatin assays as well as spatial transcriptomics of tissue sections. Cost
savings through multiplexing for single cell experiments on the 10X Chromium platform has been used to make
these assays substantially more cost-efficient, while reducing batch effects. Single cell sequencing combined
with cell surface marker studies are being provided using the Mission Bio Tapestri platform, which is a foundation
for ongoing clonal hematopoiesis research. We have increased our focus on collecting genomics data as a
resource within the GSR. Our new institutional arrangement with Caris Life Sciences to perform exome and
transcriptome sequencing on our Bronx cancer patients is accompanied by a research protocol to allow the
primary sequence data to be returned to our FISMA-compliant data storage and computing resource. These data
are made available under defined IRB protocols for researchers, to gain insights into the genomic events
occurring in the ancestrally diverse, socioeconomically disadvantaged communities of the Bronx.
Our goals for the next funding period will be to continue to support MECC researchers in their genomic assays
and data analyses. We are continuing to develop and support new assays, to invest in new equipment, and to
help analyze data generated in the GSR. Investigators are encouraged to contact the leaders of the GSR and
Biostatistics colleagues to discuss study design before initiating a project. For data analytical services, we will
continue to train lab personnel to process data independently and can troubleshoot problems with researchers.
Finally, a new goal is to tailor our services so that they allow insights into cancer genomics in the ancestrally-
diverse Bronx population, with the goal that GSR can help foster health equity and precision medicine for all.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Chu, Edward GENOMICS SHARED RESOURCE - PROJECT NARRATIVE Per PAR-21-321, a Project Narrative is not required for this Component. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page